Fully autonomous robotic wet lab for stem cell culture media optimization

PROJECT SUMMARY
Hematopoietic stem cells (HSCs) are perhaps the most important and immediately actionable cells for
cell rejuvenation therapies, but the difficulty of growing them in the lab limits their potential. To address this
problem, we are using a fully autonomous, ML-driven wet lab to optimize HSC culture media.
Our system, which we refer to as a “machine biologist”, has two major components: the “body”,
consisting of a robotic wet lab capable of performing HSC culture experiments, and the “mind”, consisting of an
machine learned (ML) computer vision model for analyzing our microscopy results and a Bayesian optimizer to
perform experimental design. This combination will allow our system to operate fully autonomously, and
proceed orders-of-magnitude faster than is possible in a conventional biology lab.
Our work has the potential for transformative impact on both the way cell biology research is conducted
as well as HSC-based cell therapies.

Public health relevance
PROJECT NARRATIVE We combine robotics and artificial intelligence to produce a “machine biologist”, a system capable of performing cell biology experiments at scale, without the need for human intervention. We plan to use this system to optimize the culture media of hematopoietic stem cells, allowing scientists to grow them in the lab for research and therapies. This will reduce costs and may make hematopoietic stem cell therapies more effective.